Modernization and Expansion of Recirculating Zebrafish Tanks and Monitoring Equipment at UNM Main Campus Castetter Hall Animal Resource Facility

PROJECT SUMMARY/ABSTRACT
The aim of this S15 proposal entitled “Modernization and Expansion of Recirculating Zebrafish Tanks and
Monitoring Equipment at UNM Main Campus Castetter Hall Animal Resource Facility” at the University of New
Mexico Castetter Hall Animal Resource Facility is a request for $180,679 to expand the existing zebrafish
facility. Specifically, the following items purchased 1) six recirculating zebrafish single sided standalone racks
with tanks/accessories with upgraded pumps and web-based off site monitoring capabilities 2) upgrading
existing three recirculating zebrafish single sided standalone racks with upgraded pumps and web-based off
site monitoring capabilities 3) three e-racks for flexible and temporary fish holding/housing and 4) an additional
chemical dosing systems, water storage tanks, and rack to rack connections for water quality in the new racks.
The total space affected by this project is 812 sf including space where equipment is sited at the University of
New Mexico (UNM) Castetter Hall (CH) Animal Resource Facility (ARF). This project is located in dedicated
and existing zebrafish housing space within the Main Campus, which also houses laboratory mice, deer mice,
hamsters, and opossums. This facility was renovated in 2015 for rodent space, 2019 for aquatics, and the
cagewasher and autoclave are being upgraded, the installation is slated for completion in September 2024.
These renovations were all made with institutional funding. Past renovations upgraded floors, finishes, light
timers, a pass-through rack washer, a pass-through cage and equipment autoclave, and renovated mouse
housing rooms to accommodate individually ventilated rodent racks in mouse housing areas. This proposal will
expand and address aquatic housing recommended under the 8th edition NIH Guide for the Care and Use of
Laboratory Animals, specifically having adequate monitoring such that off-site personnel are able to monitor
and respond to any necessary emergency. The current zebrafish facility is currently at capacity and this
proposal will enable a 132% expansion of the existing zebrafish facility, which currently houses up to 4000 fish
and 150 tanks. These proposed recirculating racks are single sided units with capacity of 75 tanks per rack.
This zebrafish research suite currently supports 4 PI laboratories. These rooms are currently near capacity and
1 new faculty with a zebrafish breeding and research program has been hired with numerous faculty recruits
discussing this important and emerging animal model.

Public health relevance
PROJECT NARRATIVE “Modernization and Expansion of Recirculating Zebrafish Tanks and Monitoring Equipment at UNM Main Campus Castetter Hall Animal Resource Facility” requests $180,679 to support purchase of 6 recirculating zebrafish racks with tanks/accessories, water quality monitoring equipment, web-based monitoring alarm upgrades, and three education training racks for fish housing. The University of New Mexico (UNM) Castetter Hall Animal Resource Facility (ARF) supports approximately 15 biomedical and behavioral research investigator laboratories and the zebrafish core aquatic facility specifically supports 5 research laboratories doing metabolism, immunology, face, organ and cell development research. This project, when completed, will allow for an increase of 132% more tank capacity, improve monitoring and water quality, and improve research space as a means to sustain ongoing strategic goals to: expand a productive partnership between the NIH and UNM; develop new synergies among research programs to enhance Main Campus in collaboration with the Health Sciences Center, advance the animal core and improve animal care to assure compliance with required standards.